INFANT AND CHILD EARLY DIAGNOSIS OF HIV

To improve methods for early diagnosis of infections caused by the AIDS virus (HIV) in newborn infants. To evaluate the risk of transmission of the virus from mother to infant.